Molecular mechanisms of histone modification

Enzyme-catalyzed histone modifications (e.g. (de)acetylation, (de)phosphorylation, and (de)methylation)
result in a unique set of chemical 'marks' that regulate chromatin function through mechanisms that remain a
focus of intense study. The combinatorial nature of these posttranslational modifications (PTMs) give rise to
a histone 'code' or 'language', which is interpreted by enzyme complexes to mediate transcriptional
responses. Importantly, these chromatin-modifying complexes have evolved to use co-substrates that are
major metabolites linked to essential metabolic pathways, a fact eliciting the possibility that chromatin
modifying enzymes exquisitely 'sense' metabolite levels (like acetyl-CoA, NAD+, SAM, 02, α-KG.) and
respond accordingly, modifying specific chromatin loci for the appropriate response in gene expression. This
proposal will investigate how metabolism and key epi-metabolite levels regulates epigenetic programs by
controlling the activity of specific acetyltransferases, deacetylases, methyltransferases, and demethylases. In
this proposal, we will investigate the hypothesis that epi-metabolite levels and the metabolic enzymes that
produce these are intimately connected to chromatin modifying enzymes and that this link is a fundamental
regulatory mechanism for controlling specific gene expression programs. To accomplish these goals, three
aims are proposed: 1.) to determine how short-chain fatty acids produced from gut microbiota affect
epigenetic control of gene expression in the host, 2) to determine the role of nuclear acetyl-CoA synthetase
in controlling histone and non-histone protein acetylation, and 3.) to elucidate how SAM (S-adenosyl
methionine) synthesis in the nucleus leads to maintenance of repressive epigenetic marks during metabolic
stress. These integrated studies will provide a deep molecular understanding of the connections between
metabolites acetyl-CoA and S-adenosyl methionine, and the dynamic regulation of chromatin modifications
(acetylation and methylation) that drive both normal and stress-response pathways of gene expression.

Public health relevance
This proposal explores how metabolism and environmental factors influence gene expression through epigenetic mechanisms. It is well established that human phenotypes and susceptibility to disease are products of genetics and external environmental factors; however, the molecular basis for their interplay remains elusive. The proposed work will determine how major metabolic pathways are linked to epigenetic modulation of gene expression. consolidating metabolic information in cellular decision-making.